Sexual Dimorphism in T Cell Exhaustion and Bladder Cancer

PROJECT 1 – SUMMARY
Sex is an understudied biological variable with significant influence on immune function, including in the context
of cancer. However, the immunological mechanisms underlying the sex bias seen in cancers from non-
reproductive organs, such as bladder cancer (BC), remain elusive. Male bias in BC incidence persists after
adjustment for other known risk factors suggesting a fundamental biological basis for this sexual dimorphism.
Objective: To define the molecular mechanisms by which androgens, AR target genes, and sex chromosome-
encoded epigenetic modifiers contribute to sex differences in CD8+ T cell exhaustion in the tumor
microenvironment (TME). Impact: Our study will uncover an immunological basis and mechanism by which
CD8+ T cell exhaustion contributes to sex bias in BC, with implications for improving ICB approaches for all
cancer via three specific aims. Aim 1: Determine the role of AR-TCF1 and AR-TOX in CD8+ T cell exhaustion
and tumor control. The molecular mechanisms by which androgens influence T cells and contribute to cancer
progression are unclear. Male CD8+ tumor-infiltrating lymphocytes (TILs) preferentially adopt a TCF1+ PE state
due to direct activation of Tcf7 by AR. Hypothesis. Androgen signaling establishes a stable TCF1-driven
transcriptional network in CD8+ T cells that favors exhaustion, through the modulation of TOX, another critical
transcription factor (TF) that promotes T cell exhaustion. Aim 2: Determine the role of AR-ZFP148 in T cell
effector differentiation. TF ZFP148 regulates cell proliferation and survival in non-immune cell types but has
not been studied in T cell biology. Single-cell RNA-seq analyses demonstrated male-biased Zfp148 expression
and regulatory activity in PE CD8+ T cells stimulated by AR. T cell receptor (TCR) engagement and chronic
exhaustion induced Zfp148 expression in CD8+ T cells, and its deletion led to better effector function in vitro. The
in vivo persistence of Zfp148 null T cells was compromised. Hypothesis. AR-regulated ZFP148 can suppress
CD8+ T cell effector function and contributes to male-biased BC. Aim 3: Investigate the role of AR and
epigenetic modifiers in CD8+ T cell exhaustion and tumor response to immunotherapy. The impact of sex
chromosome-encoded epigenetic modifiers in BC – including KDM5D, UTY, and KDM6A – on immunity
especially in the CD8+ compartment is a major gap in the field. In collaboration with Project 2, we found that loss
of the Y chromosome (LOY) (especially the genes Kdm5d and Uty) contributes to CD8+ T cell exhaustion in BC.
Hypothesis. Sex hormones and sex chromosome-encoded epigenetic modifiers contribute to CD8+ T cell
exhaustion and BC sensitivity to ICB.

Public health relevance
PROJECT 1 – NARRATIVE It is unclear why men develop many cancers (such as bladder cancer) more often than women, even after adjusting for known risk factors such as smoking. We discovered that dysfunction within the adaptive T cell immune response strongly contributes to male-biased tumor aggressiveness; this dysfunction is modulated by male hormones that reduce the anti-tumor response in T cells. The goal of this project is to characterize the sex- specific differences in T cell response to tumors and use this knowledge to improve cancer immunotherapy in both men and women.